MULTICENTER STUDY OF RH GROWTH HORMONE IN AIDS ASSOCIATED CATABOLISM/WEIGHT LOSS

This multicenter trial enrolled patients in a placebo-controlled trial of rhGH in patients with HIV-associated wasting. All subjects are now on open-label therapy and are undergoing long term followup.